Leveraging inpatient antimicrobial stewardship infrastructure to improve antimicrobial-prescribing at hospital discharge

Background: Antimicrobial overuse is one of the strongest risk factors for the emergence of antimicrobial
resistance, an urgent public health problem. Antimicrobial stewardship programs (ASPs) are hospital-based
programs that can reduce unnecessary inpatient antimicrobial use and are therefore an essential tool for
addressing the crisis of antimicrobial resistance. ASPs are mandated in VHA.
Significance: VHA hospitals are only required to monitor their inpatient antimicrobial use. However, at least
40% of antimicrobial exposure associated with a VHA hospital stay is prescribed at hospital discharge and is
taken by the patient after discharge (i.e. post-discharge). These post-discharge antimicrobial prescriptions are
frequently unnecessary or sub-optimal. Reducing post-discharge antimicrobial overuse will minimize patient
harm, such as Clostridioides difficile infections, antimicrobial resistance, and adverse drug events.
Innovation and Impact: This proposal will address two critical gaps in the literature. First, standard ASP
metrics do not capture post-discharge antimicrobial use and therefore miss a substantial amount of hospital-
related antimicrobial exposure. This proposal will evaluate factors that contribute to variation in post-discharge
antimicrobial use across patients and hospitals in order to inform both metric development and the design of
future stewardship interventions. Second, while there are evidence-based strategies for safely reducing
inpatient antimicrobial use, it is unclear how current inpatient ASP activities can decrease post-discharge
antimicrobial overuse. This proposal will explore how inpatient ASP infrastructure, which all VHA hospitals are
expected to have, can be leveraged to reduce unnecessary post-discharge antimicrobial-prescribing.
Specific Aims: Aim 1: Identify factors that contribute to variation in post-discharge antimicrobial use in VHA
acute-care admissions across all facilities by evaluating potential patient-level, hospital-level, and
environmental effects. Identify hospitals that have low observed-to-expected post-discharge antimicrobial use,
low risk-adjusted inpatient antimicrobial use, and perform well on clinical outcomes in antimicrobial-treated
patients. Aim 2: Determine whether being admitted to a hospital with a discharge-focused stewardship process
is associated with less post-discharge antimicrobial exposure, after adjusting for differences in case-mix, ID
expertise, inpatient antimicrobial exposure, and the intensity of inpatient ASP activities. Aim 3: Using qualitative
methods, evaluate attitudes and processes that impede or foster reductions in unnecessary post-discharge
antimicrobial use. We will perform site visits at 6 high- and 4 low-performing sites, as identified in Aim 1.
Methodology: Aim 1 will use VINCI data and linear mixed models to identify factors that influence post-
discharge antimicrobial use. Aim 1 will also rank hospitals on their performance on inpatient and post-
discharge antimicrobial use plus associated clinical outcomes. In Aim 2, we will leverage VINCI data and
findings from a mandatory hospital-level stewardship survey conducted in VHA during November 2020. We will
evaluate the effect of a discharge-specific stewardship process on post-discharge antimicrobial use. In Aim 3,
we will conduct semi-structured interviews with key stakeholders at 10 hospitals to explore determinants of
post-discharge antimicrobial overuse and perceptions of the post-discharge antimicrobial use metric that we
developed in Aim 1. Our approach will be based in the i-PARIHS framework.
Next Steps/Implementation: The standardized hospital-level metrics we develop in Aim 1 could be
incorporated into an interactive ASP dashboard our Patient Safety Center of Inquiry has already built and is
pilot-testing in VISN 23. Our findings from Aims 2 and 3 could be incorporated into future stewardship surveys
within VHA while informing the processes local ASPs choose to implement to reduce post-discharge
antimicrobial overuse. Our findings could serve as the basis for a multicenter, audit-and-feedback trial focused
on stewardship at hospital discharge and future work around re-designing ASP processes at discharge.

Public health relevance
Antimicrobial use is one of the strongest risk factors for the emergence of antimicrobial resistance. Antimicrobial stewardship programs (ASPs) can minimize unnecessary antimicrobial use and are thus an essential tool for addressing the crisis of antimicrobial resistance. The VHA has mandated that every VHA hospital have an ASP, but ASPs tend to focus on antimicrobial use administered to patients while hospitalized without addressing antimicrobial use in the 20% of patients who are discharged on an antimicrobial. This proposal will identify hospitals that are having good clinical outcomes while prescribing less antimicrobials to patients both while they are hospitalized and at the time of discharge. The project team will study the processes these high-performing hospitals are using to improve antimicrobial use at discharge. Across all VHA sites, the team will evaluate whether a specific stewardship process at discharge is beneficial.